Beta Cell Heterogeneity in the Interferon Alpha Response

1 PROJECT SUMMARY
2 Type 1 Diabetes (T1D) is an autoimmune disease characterized by destruction of insulin producing β-cells due
3 to a combination of genetic risk and an unknown environmental trigger. A leading hypothesis for the
4 environmental trigger is viral infection, during which the innate immune system releases various cytokines and
5 interferons. Interferon alpha (IFN-α) has been long implicated in disease pathogenesis, with its presence
6 observed in islets of donors with early-onset T1D. It has also been shown that IFN-α induces ER stress, MHC
7 class 1 overexpression, and islet apoptosis, classical hallmarks of T1D development. For many years it was
8 thought that all β-cells were destroyed in individuals with T1D. Recently, this dogma has been challenged with
9 the discovery of residual insulin positive β-cells in donors with long-standing T1D. This suggests that β-cells are
10 heterogeneous, with one population of β-cells able to survive conditions of high stress. With these observations
11 in mind, the central goal of this proposal is to understand mechanisms behind heterogeneity of human β-cell
12 ROS response following IFN-α insult. I hypothesize that ROS accumulating β-cells, termed ‘ROSponders’
13 contain a unique molecular signature that promotes this heterogeneity in ROS accumulation, causing this subset
14 of cells to be more susceptible to oxidative stress and apoptosis. I will test this hypothesis through three specific
15 aims. Experiments in aim 1 are designed to characterize the molecular signature of ROSponders, with the goal
16 of identifying what makes them more susceptible to this ROS accumulation. In aim 2, I will determine the origin
17 of accumulating ROS. In aim 3, I will determine the fate of ROSponders through longitudinal intravital imaging.
18 With completion of these aims, the goal is to determine the mechanism and consequence of this observed
19 heterogeneity in ROS response. Importantly, through transcriptomics, this work will aim to identify novel targets
20 to prevent β-cell dysfunction under diabetogenic conditions, allowing for the development of future therapeutics
21 for disease prevention and/or treatment. A comprehensive understanding of islet function in early diabetes
22 pathogenesis and the use of cutting-edge techniques proposed in this grant will enable me to develop as a
23 scientist and set me on a trajectory to make real and lasting impacts in the field of diabetes. This F31 award
24 includes a 2-year training plan designed to achieve 4 main objectives: 1) develop a strong comprehension of
25 techniques and concepts used in diabetes research, 2) train in the use of different microscopy techniques, 3)
26 enhance written and oral scientific communication, and 4) train in the use and handling of mouse models for
27 diabetes research. In addition, I will benefit from the collaborative research environment provided by the Center
28 for Diabetes and Metabolic Diseases at the Indiana University School of Medicine. I will also benefit from an
29 advisory committee consisting of a diverse team of carefully selected and established NIH funded investigators
30 and a supportive research environment in the laboratory.
31
32
33
34

Public health relevance
PROJECT NARRATIVE In recent years, there has been an increase in the prevalence of Type 1 Diabetes (T1D), and yet we still do not understand the mechanisms that lead to β-cell dysfunction and destruction in disease pathogenesis. The goal of this project is to provide comprehensive training and career development opportunities to Ms. Wagner as she works to understand the role of heterogenous β-cell reactive oxygen species (ROS) presence in disease development and determine the molecular signature behind this observed heterogeneity. The aim of this project is to address the gap in our knowledge of intrinsic mechanisms of β-cell dysfunction and has the potential to spark the development of novel therapeutics to treat and prevent T1D.